Characterization of novel regulators of embryonic stem cell self-renewal

Embryonic stem cells (ES cells) are pluripotent cells derived from the inner cell mass of the blastocyst-stage embryo. They can be used as a model system to study the molecular basis of pluripotency and fate-specification during early mammalian development. They can also be used to derive various types of cells for disease modeling, drug discovery, and the development of cell-based therapies. However, the success of these studies and applications critically depends on the understanding of the mechanisms that control ES cell self-renewal and differentiation. To systematically study ES cell self-renewal, we have previously carried out a genome-wide siRNA screen in mouse ES cells and successfully identified a list of novel genes that are important self-renewal. We are currently investigating the function of several of these novel genes in ES cells with biochemical, genetic, and genomic approaches. Specifically, we have found that three of the Cnot family genes, Cnot1, Cnot2, Cnot3, play important roles in self-renewal, form a complex in mouse ES cells, and co-regulate a large set of genes. We are generating conditional knockout ES cell lines and mice to further study their function in ES cells as well as mouse embryogenesis. We are testing their function in the generation of induced pluripotent cells. In addition to the Cnot complex, we are beginning to investigate the roles of several other protein complexes in ES cells as well, and we will use similar approaches to dissect their function in self-renewal and/or pluripotency. Besides the characterization of the newly-identified self-renewal factors, we are going to collaborate with NCGC and NTP and continue to use functional genetic and chemical genetic approaches to identify and probe new genes and networks involved in the stem cell fate specification. We plan to study the guided-differentiation of ES cells and the self-renewal of other types of stem cells, in the hope that our studies will facilitate the development of stem cell therapies. We plan to study the expression and the roles of stem cell genes in cancer, in the hope that we can identify novel therapeutic targets or diagnostic markers for cancer treatment. We also plan to study the effect of environmental chemicals on ES cell development, in the hope that we can have a better understanding on the impact of environmental factors on human embryogenesis and embryonic development. In summary, we use ES cells as a model system to investigate the mechanism of stem cell self-renewal and differentiation. Our studies will lead to a better understanding of developmental biology, and it will contribute to the advance of the therapeutic use of stem cells in regenerative medicine, as well as the use of stem cells in the study of environmental sciences.